Engineering Immuno-Glial-Neurovascular 3D-Brain-Chips with a Perfusable BBB for Accelerating Alzheimer’s Disease Drug Discovery and Translation

PROJECT SUMMARY. While Alzheimer’s Disease (AD) is the sixth leading cause of death, there is still no
pharmacologic treatment on the market that slows or stops neuronal damage in AD. Apolipoprotein-E4 (APOE4)
is the strongest genetic risk factor for sporadic AD and one that roughly a quarter of the general population
carries. Importantly, further precluding effective therapeutic development is the lack of human-based models that
can recapitulate AD pathology with all the brain-resident cell types in the immune-glial-neurovascular unit, cap-
turing critical cell non-autonomous effects, including in inflammatory and lipid dysregulation, and blood brain
barrier (BBB)-mediated transport of nutrients and therapeutics. To address these limitations, in an ambitious
moonshot project in the first phase of my postdoctoral work, I have engineered a novel brain-mimetic matrix
(NeuroMatrix) that supports the co-culture of all 7 brain cell types from patient-specific induced pluripotent stem
cells with mature phenotypes to form a multi-cellular integrated brain model (miBRAIN). This model recapitulates
APOE4-associated dysregulation and AD pathological hallmarks of neuronal hyperexcitability, amyloid accumu-
lation, phosphorylated tau burden, etc. Further, I have developed a novel constriction-minimizing microfluidic
device that enables perfusable vasculature within neurovascular units self-assembled in NeuroMatrix. I propose
here to: (Aim 1) leverage the miBRAIN platform to construct a diverse “in vitro patient cohort” across
APOE genotype with isogenic lines to probe APOE4-specific effects and conduct important validation of
the model as I aim to hone this platform technology for broad utility and (Aim 2) engineer 3D-miBRAIN-
Chips by combining my novel microfluidic devices with the miBRAIN and successively integrating each cell type
towards a fully perfusable BBB within miBRAIN culture and harness them to functionally assess BBB perme-
ability and selectivity across patient cell lines and APOE status. After consultation with the Program Officer
and given my long-term goals, I have decided to further focus on (Aim 3) investigating the best path forward
for deploying this technology for maximal utility, including development of a business plan and identification
of potential partners and focus applications. This work thus could result in important insights for AD mechanistic
understanding, of immediate relevance to other neurodegenerative diseases associated with APOE4 risk, while
developing a well-validated 3D-miBRAIN-Chip platform technology that is an integrated immune-glial-neurovas-
cular unit with patient-specific genetics and biomimetic phenotypes and functions that could be of great utility for
therapeutic development across CNS pathologies. Simultaneously, it provides vital training in research meth-
ods (platform development, bioinformatics, lipidomic and inflammation analyses, mentoring from expert Co-
Mentors and Scientific Advisory Committee) and career development (immersive entrepreneurial training,
niche-specific coursework, mentoring from expert Co-Mentors and Entrepreneurial Advisory Committee, pursuit
of ambitious independent vision) that will make a marked difference in launching my independent career.

Public health relevance
Alzheimer’s Disease (AD) is the sixth leading cause of death, but its treatment has been hindered by a lack of human-based models that can mimic key aspects needed to mimic its pathogenesis and treatment: (1) the non- cell autonomous effects of glial, immune, and blood-brain barrier (BBB) cells on the pathology and (2) a 3D BBB that mimics the permeability and selectivity of the human in vivo BBB. To this end I have recently developed a multi-cellular integrated brain (miBRAIN) immuno-glial-neurovascular unit that includes all of the brain-resident cell types that recapitulates key phenotypic and functional phenotypes of the human brain, with enhanced in vivo-like signatures compared to their monocultured counterparts, that I propose to combine with custom microfluidic devices I invented to create and validate 3D-miBRAIN-Chips towards matching human BBB permeability and selectivity in vitro. I will harness these models to probe the effect of the strongest genetic risk factor for sporadic AD, APOE4, constructing and meticulously screening a diverse “in vitro patient cohort,” rigorously validating the platform with a view to translating the technology for maximal utility as an engine for accelerated therapeutic development for AD and other neurodegenerative diseases.